BIOMEDICAL RESEARCH SUPPORT

We propose to replace the only scanning electron microscope in the Division of Biology and Medicine at Brown University with a new high resolution analytical instrument. The current instrument will be 15 years old in April 1989, has become unreliable and cannot accommodate technical modifications to take advantage of newer techniques in scanning electron microscopy. The proposed instrument will not only have increased reliability and resolution, but also these new features: (1) low voltage surface imaging, (2) backscatter imaging, (3) energy dispersive x-ray analysis. These capabilities are essential for the research programs of the four major users: mechanisms of mineral fiber carcinogenesis, tissue-polymer interactions in artificial organ implants, mechanisms underlying peripheral nerve regeneration, and development of surface membranes in human parasites. The proposed microscope will also benefit other scientists in the Division of Biology and Medicine who require high resolution surface imaging and quantitative techniques for immunoelectron microscopy. The proposed instrument will be incorporated into the existing centralized Electron Microscope Facility in the Division of Biology and Medicine at Brown University. This facility has been operating efficiently for the past 13 years, but with the growing number of projects served by it, has outgrown the existing facilities. Thus a new centralized facility is planned in a building now under construction, an addition to the Brown University Medical School. The new building which will be completed in the summer of 1989, will house the new scanning electron microscope along with two transmission electron microscopes, laboratory space, darkrooms, and other ancillary equipment for electron microscopy. Brown University provided $40,000 toward the purchase of a new transmission electron microscope in 1983, the renovation costs of the present facility, and has committed continuing funds for the salary of a full-time electron microscopy technician. Brown University will also provide construction costs for the new 3000 square foot facility and $40,000 towards the purchase of the proposed instrument. Maintenance of the instruments in the Electron Microscope Facility and other operating costs will be covered through user fees.